Hormonal contraception choice and safety among people with sickle cell disease

Project Summary
Estrogen-containing hormonal contraception and injectable progestin-only contraception have been associated
with venous thromboembolism (VTE) and stroke in the general population. However, little is known about the
safety of these contraceptive methods among people with sickle cell disease (SCD) even though around 25%
of people with SCD experience VTE with a mean age at diagnosis early in the reproductive lifespan. This
critical gap in knowledge affects contraceptive counseling from both the clinician and patient’s perspectives. In
fact, unplanned pregnancy is more common among people with SCD than the general population suggesting
this population faces multifaceted impediments to contraceptive access. Further, the burden of having a
serious chronic disease is compounded by the fact that, in the United States, SCD disproportionately affects
people with African ancestry (1 in 365 births) and the responsibility of contraception largely falls on women.
Thus, people with SCD are more likely to experience a high burden of social stressors, socioeconomic
disadvantage, and poor quality of life; all of which may contribute to sub-optimal contraception use. Our
overarching goal is to improve the quality of care for people with SCD by assessing the safety of different
hormonal contraceptive methods in this population and by holistically evaluating patient and provider factors
that affect the use of different contraceptive options. To address this goal, we will leverage health system data
from Kaiser Permanente Mid-Atlantic States, which includes approximately 1,642 women with SCD enrolled
from 2001-2022. We will augment these data with patient surveys and semi-structured interviews of their
providers. Our research will be guided by a Patient Advisory Board. Aim 1 will use health system data to
compare the risk of SCD complications (VTE, stroke, myocardial infarction, and SCD pain crisis) for people
initiating estrogen-containing contraception versus progestin-only contraception. We will use the state-of-the-
art target trial emulation framework to compare people initiating different contraceptives methods (new user-
active comparator design). Aim 2 will evaluate which patient characteristics are associated with the use of
different types of hormonal contraception using health system data and patient survey data (n=250) that
address the knowledge and attitudes of people with SCD towards different contraceptive methods. Aim 3 will
use semi-structured interviews, informed by a mixed-methods sequential explanatory design, to evaluate the
knowledge and beliefs of clinicians (n=25) regarding hormonal contraception for people with SCD. Impact: This
work addresses the NICHD priority Effects of Long-Term Contraceptive Use on Health with a special focus on
racial minorities and people with chronic conditions by directly assessing the safety of different contemporary
contraceptive methods in an historically understudied population. Further, by examining patient and clinician
factors that affect contraception choice, this work will provide the foundation for a future study evaluating how
best to integrate our findings about contraceptive safety and preferences into clinical practice.

Public health relevance
Public Health Relevance Some types of hormonal contraception have been associated with an increased risk of adverse cardiovascular outcomes, but the safety of these contraceptives has not been well studied among people with sickle cell disease (SCD) even though they have an elevated risk for these outcomes. Further, people with SCD are more likely to have an unplanned pregnancy than the general population, but little is known about what factors affect contraceptive decisions in this population. Results from the proposed study would help inform patient-centered contraceptive counseling for people with SCD by evaluating the safety of different contraceptive methods and examining patient and provider factors that affect contraceptive choices.